Core-005

Hub Research Capacity goals are to provide UMCCTS resources that ensure diverse participant engagement in CTR and that add value by facilitating the efficiency and quality of CTR throughout the research cycle, from study planning through dissemination of results. The UMCCTS Science Participation Research Center (SPRC) supports diversity in research recruitment and retention by partnering with CECC and our communities to advance research literacy through community forums with dialogue and bi-directional learning, enabling mastery of cultural competency skills through medical simulation training, and by providing a consult service that helps investigators to improve engagement of diverse populations in research. Our new Translational Research Accelerator (TRAcs) provides a framework for integrated UMCCTS services. TRAcs incorporates SPRC and CECC expertise into a newly-formed Protocol Review Committee and other processes focused on timely, culturally-sensitive protocol development, participant recruitment, and dissemination of research results.

Public health relevance
Hub Research Capacity describes UMCCTS resources that ensure participant engagement in CTR that reflects the health needs of a diverse society and that add value to CTR by facilitating the efficiency and quality of CTR throughout the research cycle, from study planning through dissemination of results. Our network of community partners, clinical systems, and UMass campuses serve and interact with diverse community settings that include populations such as rural, low socio-economic status, immigrant, Hispanic, African American, Older Adults, Pediatric, and LGBTQIA+, among others.